System for Measuring Tissue Oxygenation

? DESCRIPTION (provided by applicant): Advanced Medical Electronics (AME) and our partners propose a minimally-invasive system for calibrated and repeatable measurement of peripheral tissue oxygenation. An optically coupled oxyphor-based micro-sensor approach is proposed based on Pd-tetrabenzoporphyrin modified with generation-3 polyarylglycine dendrons and coated with a layer of polyethylene glycol. Teflon AF chambers will be utilized to sequester the Oxyphor solution from contact with the body and the system provides a measurement of oxygen pressure by phosphorescence quenching. Sensor response time is estimated to be less than one minute with stability for greater than 16 hours. Advantages to the approach include a robust, quickly inserted and minimally invasive device with absolute calibration. In phase 1, a prototype system will be specified, developed, and evaluated.

Public health relevance
PUBLIC HEALTH RELEVANCE: The project seeks to develop a device to evaluate dynamic changes in microvascular blood flow and tissue oxygenation. The device will have utility in measuring temporal changes in regional perfusion and oxygen delivery following red blood cell transfusion or in peripheral vascular disease therapy monitoring. (End of Abstract)